Therapeutic roles of hepatocyte exosomes in the liver

ABSTRACT
The broad long term objective is to improve methods of disease treatment in the liver. Hepatic fibrosis is a
major cause of morbidity and mortality that affects millions of people world-wide and is usually a feature of
chronic liver disease such as that caused by excessive alcohol consumption. In the United States, alcoholic
liver disease (ALD) is a leading cause of GI-related deaths, with about half of the 75,000 liver disease deaths
each year being related to alcohol use. A major limitation is the lack of approved therapeutics for treating either
liver fibrosis or ALD. However, a new lead has emerged from our studies of exosomes that are produced by
hepatocytes. Our overall objective is to establish therapeutic uses of exosomes for treating liver disease. Our
Preliminary Data show that hepatocyte exosomes: (i) attenuate expression of genes that regulate fibrogenesis
or activation in cultured primary hepatic stellate cells (HSC); (ii) suppress fibrogenic pathways and reverse
hepatic fibrosis in vivo; (iii) attenuate damage in cultured hepatocytes exposed to ethanol or CCl4, (vi) contain
relatively high levels of miR-532-5p or miR-214 that likely contribute, in part, to their therapeutic actions in
fibrosis or ALD respectively especially as their respective tissue levels in the liver are individually suppressed
during chronic injury; and (v) bind to target hepatocytes or HSC via cell-surface integrin αvβ3 and α5β1. Our
central hypothesis is that miR-532-5p-/miR-214 or specific integrin ligands contribute to, respectively, the
therapeutic actions or cellular binding of hepatocyte exosomes. The Specific Aims to test this hypothesis are:
Aim 1 - Identify miR-532-5p as a therapeutic component of hepatocyte exosomes that modulates
SMAD3 in hepatocytes or HSC by using purified exosomes or cell co-culture assays, employing SMAD3 3’-
UTR reporters, CTGF promoter reporters, expression of SMAD3 downstream targets, siRNA-mediated SMAD3
knockdown, and miR-532-5p over-expression or antagonism to show direct functional regulation of SMAD3 in
each target cell; Aim 2 - Determine the role of hepatocyte exosomes and of exosomal miR-214 or miR-
532 in attenuating ethanol-induced liver injury by demonstrating the therapeutic effect of exosomes in
ethanol diet models in vivo, on ethanol/TNFα- or LPS-mediated pathways in hepatocytes or Kupffer cells
respectively, and by demonstrating that exosomal targeting of CTGF or ICAM-1 by miR-214 or of SMAD 3 by
miR-532 recapitulates exosomal action in vivo and in vitro; and Aim 3 - Identify exosomal binding partners
of cellular integrins by establishing the role of hepatocyte FN, VN, or CTGF in engaging integrin αvβ3 or
α5β1 on HSC or hepatocytes and thereby mediating target cell binding. The rationale is that current methods
of treating liver fibrosis or ALD are inadequate and our approach is a cutting-edge and innovative solution that
harnesses natural disease-suppressing properties of exosomes. The expected outcome will be a novel
exosome-based therapy for treating fibrosis or alcohol-induced cell damage and altered immune function in the
liver. The positive impact will be to improve the health of millions of people globally with chronic liver disease.

Public health relevance
NARRATIVE Exosomes are small secreted vesicles that bind to target cells resulting in the delivery into the cells of a molecular “payload” that causes the cells to change their behavior. This grant application seeks to understand the therapeutic actions of exosomes in liver fibrosis or alcoholic liver disease. These studies will establish that exosomes produced by healthy liver cells can reprogram and heal liver cells which have been damaged by exposure to alcohol or that are involved in the production of scar material during chronic injury.